CK25-182 - Puerto Rico Enhanced Surveillance and Control of Endemic and Emerging Arboviruses

ABSTRACT
Dengue, chikungunya, Zika, and Oropouche viruses pose a growing threat to public health, with Puerto Rico
(PR) serving as a critical transmission hotspot in the Americas. These arboviruses cause frequent outbreaks,
straining public health systems due to overlapping clinical presentations that complicate diagnosis and response
efforts. Dengue alone remains endemic in over 100 countries, while emerging threats like chikungunya, Zika,
and Oropouche disproportionately affect immunologically naïve populations, exacerbating disease burden. The
urgent need for improved surveillance and response strategies aligns with U.S. government priorities on vector-
borne disease control and health security. The Puerto Rico Enhanced Surveillance and Control of Endemic and
Emerging Arbovirueses (PRESCA) aims to enhance the detection, characterization, and response to arboviral
pathogens by integrating clinical, community-based, and laboratory surveillance data. PRESCA’s central
hypothesis is that a strengthened surveillance infrastructure will improve early detection and outbreak response,
mitigating the public health impact of arboviruses in PR. To achieve this, PRESCA proposes to (1) strengthen
surveillance and research capacity for acute febrile illnesses (AFIs) to improve the detection and response to
emerging and re-emerging arboviruses and (2) enhance data management, analytics, and collaborative
networks to sustain AFI surveillance and research. This initiative leverages existing platforms such as SEDSS
and COPA and fosters collaboration with the CDC Dengue Branch, Puerto Rico Vector Control Unit (PRVCU),
and local public health entities. PRESCA aligns with federal priorities by integrating AFI surveillance, community-
based research, and predictive modeling to improve vector control and outbreak response. The expected
outcomes will establish PR as a regional model for arboviral surveillance, strengthening public health
preparedness across the Americas. Timely case identification will improve response efforts, reduce disease
spread, and minimize economic and healthcare burdens. Enhanced vector control strategies, targeted public
health messaging, and advanced data analytics will enable efficient allocation of resources, reducing
transmission risk and improving epidemiological forecasting. Strengthened human resource capacity will ensure
long-term sustainability of surveillance systems. By addressing critical gaps in arboviral outbreak management,
PRESCA will advance proactive, data-driven interventions that protect vulnerable populations and inform future
public health strategies.

Public health relevance
PROJECT NARRATIVE This proposal aligns with CDC goals and priorities by advancing the prevention and control of arboviral diseases and critical public health challenges surrounding the transmission of endemic, emerging, and re-emerging pathogens. The project furthers the agency’s mission of protecting health and improving responses to infectious diseases by integrating and strengthening disease surveillance, best clinical practices, vector control strategies, and community perceptions. The findings from this work contribute to evidence-based public health interventions, enhance preparedness, and reduce the burden of arboviral diseases, helping to further the CDC’s commitment to save lives, protect communities, and improve health outcomes.